Audiovisual integration for spoken language in adverse listening situations

DESCRIPTION (provided by applicant): The proposed project will enhance our knowledge of the neurophysiology of AV integration in spoken language. A neural model, whose key claims are supported by preliminary data, guides the experiments in the two aims, which use EEG, fMRI, and behavioral techniques to elucidate the functioning and interconnectivity of the brain structures involved in AV integration. Future work will extend the aims to a wider range of listening environments and clinical populations. These include individuals with hearing loss and those with cochlear implants (in collaboration with faculty in the departments of Speech and Hearing and Psychology and the PI's home department - Otolaryngology).

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research will expand our current knowledge about the brain mechanisms that underlie the integration of auditory (speech) and visual (mouth movements) information in spoken language understanding in noisy environments (e.g., degraded speech, multi-talker "cocktail party", and video chatting over a slow internet connection). Such understanding should position us well to study the neural adaptation that individuals with hearing loss, language deficits and other multisensory disorders (e.g., autism) undergo to maintain intelligibility in AV adversities. In turn, this should contribute to interventon and treatment strategies for these populations.